Endocannabinoids and the development of extinction recall neural circuitry in adolescents

PROJECT SUMMARY/ABSTRACT
Anxiety disorders are characterized by a failure to appropriately inhibit or extinguish fear. Successful extinction
learning, and its later recall depend on hippocampal (HPC)-ventromedial prefrontal cortex (vmPFC) circuitry,
and adults with posttraumatic stress disorder (PTSD) show decreased activation and connectivity between
these regions and poor extinction recall. Growing research establishes the key role of the endocannabinoid
(eCB) system in modulating fear extinction and underlying HPC-vmPFC circuitry, making the eCB system a
novel mechanistic and therapeutic target for anxiety disorders. Emerging data from animal models suggest that
eCB signaling peaks and falls sharply during early adolescence and then stabilizes in late adolescence as
individuals approach young adulthood, which corresponds with the emergence of anxiety disorders. However,
there is limited evidence of how eCB signaling changes in humans across adolescence, and potential links
between eCB signaling and extinction recall and underlying HPC-vmPFC circuitry. The goal of this training
project is for PI Marusak to develop conceptual and methodological expertise, and an independent scientific
research program, to evaluate in adolescents the novel hypotheses that: (1) fear extinction recall ability
increases across adolescence, (2) age-related increases in extinction recall correspond with increased
activation of HPC-vmPFC circuitry, and (3) higher blood levels of the eCB anandamide (AEA) correspond with
better extinction recall and/or higher activation within HPC-vmPFC circuitry among adolescents. Engaging in
this protected training time will allow the PI to develop an innovative, translational program of research focused
on adolescent anxiety that fills a unique niche by bridging her background and training in neural development,
childhood adversity, and neuroimaging with emerging expertise in 4 new areas: (1) translational research on
fear and fear-related pathology, (2) cannabinoid neurobiology and pharmacology, (3) clinical trials design and
statistical analysis, and (4) career development. The research and training plan take advantage of the breadth
and expertise of the mentorship team in fear conditioning and extinction, anxiety disorders, and novel eCB
treatments in adults (Mentor Rabinak), trauma, anxiety disorders, and fear conditioning and extinction, in
children, adolescents, and adults (Co-Mentor Jovanovic), human pharmacology, affect, and substance use
disorders (Co-Mentor Greenwald), and molecular neurobiology and animal models of fear-based learning (Co-
Mentor Lee). Co-Mentor Ghosh is a biostatistician with expertise in clinical trials design and statistical analysis.
Together with the rich environment of Wayne State University, this Award will provide the focused training and
pilot data needed for a productive independent career dedicated to advancing our understanding of
neurodevelopmental mechanisms leading to anxiety disorders, and to using that knowledge to develop more
effective interventions to circumvent the development of anxiety in at-risk youth (e.g., lower income, exposed to
adversity).

Public health relevance
PROJECT NARRATIVE Anxiety disorders are characterized by a failure to appropriately inhibit or extinguish fear, and growing research establishes the key role of the endocannabinoid (eCB) system in modulating fear extinction and underlying cortico-limbic circuitry. Despite evidence that anxiety disorders frequently emerge during adolescence, and data from animal models showing dramatic changes in eCB signaling during adolescence, there is limited research on fear extinction in human adolescents and potential links with eCB signaling. Examining fear extinction and underlying cortico-limbic eCB circuitry during adolescence should provide new insights into mechanisms leading to the development of adolescent anxiety and identify new targets for intervention.